Elucidating the Role of NAD+ and PARylation in Nephron Endowment

Background: There is broad variation in nephron endowment in humans; infants born with fewer nephrons
have increased risk of chronic kidney disease (CKD) in adulthood. Nicotinamide adenine dinucleotide (NAD+)
is a critical co-factor in most energy producing reactions. It is synthesized from nutritional precursors.
Published work proposes that NAD+ availability affects kidney health from development through to disease in a
potentially poly(ADP-ribose) polymerase 1 (PARP1)-dependent fashion. Fetuses are frequently exposed to
maternal conditions that lower NAD+ abundance including malnutrition and diabetes. These conditions are
also associated with reduced fetal nephron endowment (oligonephronia) and adulthood CKD. Little is known
about the direct impact of maternal NAD+ on fetal nephrogenesis. My preliminary data in mice show that
maternal NAD+ deficiency can cause oligonephronia that can be rescued by maternal supplementation of
NAD+ precursors. Published data show that NAD+ dependent PARP1 plays a role in progenitor cell
differentiation in multiple cells and tissues during development.
Hypothesis: I hypothesize that reduced maternal NAD+ precursor availability may impair fetal nephrogenesis
by reducing nephron progenitor cell (NPC) PARP1 activity.
Aims: In this proposal, Aim 1 will study how exogenous NAD+ affects NPC differentiation. Aim 2 will assess
how cellular compartmentalization of NAD+ influences nephron progenitor cell differentiation using innovative
biosensors to characterize how NAD+ biosynthesis compartmental fluxes change through renal development.
Aim 3 will elucidate if and how PARP1 mediates the effect of NAD+ on nephrogenesis. The findings from these
Aims may provide novel insight into the nutritional aspects of the maternal-fetal interactions that influence renal
development and may suggest therapeutic targets for developmental nephron augmentation.
Impact: This five-year proposal will provide the training and mentorship necessary for me to develop into an
independent investigator studying the metabolism-driven phenomena of renal development, with a specific
focus on NAD+. To accomplish this, I have developed a detailed career development plan integrating the
outstanding mentorship and scientific environment at UT Southwestern with focused training in developmental
biology to successfully transition to independence as an expert at the intersection of metabolism, nutrition,
maternal-fetal health, and kidney development.

Public health relevance
Pregnant mothers frequently have health concerns that reduce the level of a nutrient called NAD+ in their bodies. This may affect the development of baby’s kidneys so that they are born with less kidney filters, called nephrons -- a phenomenon that has health risks for the child that last into adulthood. The goal of this application is to determine how NAD+ affects the development of the baby kidneys and how it may be possible to enhance kidney development so that children may have healthier kidneys throughout their lifespans.